RH1GF-1 AND NUTROPIN IN INDUCING WEIGHT GAIN IN PATIENTS WITH HIV WASTING

The goal of this study is to assess whether weight gain can be induced in HIV positive patients who have lost greater than 10% of their body weight or have a body mass index of less than 19.8 and also to sequentially measure T helper/T suppressor cell ratios in this patient population.